Enabling precise cell-type-specific dissection of orientation and memory circuits in retrosplenial cortex

PROJECT SUMMARY/ABSTRACT
In humans, damage to a brain region called the retrosplenial cortex leads to pronounced spatial disorientation
and severe retrograde and anterograde memory deficits. Similar navigational and memory impairments are also
seen in rodents with either lesions or chemogenetic inactivation of the retrosplenial cortex. Despite its critically
important functions, the cells, circuits, and computations of the retrosplenial cortex remain understudied,
especially when compared to those of the hippocampus and entorhinal cortex.
We have recently shown that a small, excitable, pyramidal neuron – only found in layers 2/3 (L2/3) of the granular
retrosplenial cortex (RSG) – has properties that are very different from its more standard (regular-spiking; RS)
neighbors and is uniquely suited to computing compass-like directional information over long durations. We have
named this neuron the Low Rheobase (LR) cell. Using optogenetic ex vivo circuit mapping, we have
subsequently found that inputs from the thalamus (source of directional information) and from the dorsal
subiculum (source of spatial information) converge selectively onto these small LR cells, while avoiding nearby
RS cells. Thus, LR neurons are ideally positioned to support the RSG’s spatial orientation computations.
During non-REM sleep, hippocampal ripples (known to be important for memory consolidation) are propagated,
via the dorsal subiculum, to L2/3 of the RSG. Since these dorsal subicular outputs selectively recruit LR but not
neighboring RS cells, LR neurons are also ideally positioned to play a central role in the consolidation of
memories from the hippocampus to the RSG. Despite this strong rationale to dissect the behavioral role of
LR cells in vivo, two critical hurdles remain to enable a TargetedBCP R01 submission in the near future. First, it
is technically challenging to electrophysiologically record from large numbers of simultaneous LR cells in vivo.
This is because they are located within a narrow ~120 um band of RSG tucked away close to the midline, with
vertical access prevented by blood vessels. Second, the transcriptomic signature of LR neurons remains
unknown, preventing the rational selection or production of transgenic mouse lines that selectively and
specifically label LR neurons. To overcome these hurdles, in Aim 1, we will develop and test custom-designed
probes optimized to record large numbers of L2/3 RSG neurons. In Aim 2, we will utilize Allen Brain Institute
databases, 10x Next-Gen sequencing, and Patch-seq to identify the transcriptomic class corresponding to the
morphophysiological class of LR neurons. The completion of these Aims will set the stage for a subsequent
TargetedBCP R01 submission that will utilize large-scale recordings and causal opto/chemogenetics to carefully
decipher the importance of LR neurons in the representation and consolidation of spatial information.

Public health relevance
PROJECT NARRATIVE Damage to a brain region called the retrosplenial cortex leads to pronounced spatial disorientation as well as severe memory deficits, but the retrosplenial cells, circuits, and computations supporting healthy orientation and memory processing remain poorly understood. We have identified a unique, small, excitable neuronal subtype within the retrosplenial cortex that is ideally positioned to support its spatial orientation and memory functions. Here, we create novel electrodes and build comprehensive transcriptomic maps to enable the future cell-type-specific dissection of orientation and memory circuits within the retrosplenial cortex.